Heterocyclic Inhibitors of QcrB as Novel Drugs for Tuberculosis

Project Summary/Abstract
1 Tuberculosis (TB), caused by infection with the bacterium Mycobacterium tuberculosis (Mtb), is a leading
2 cause of mortality due to infection, globally. In 2019, 10 million people were newly diagnosed with TB and 1.5
3 million people died from the disease. As efforts to treat TB expand, the prevalence of infections caused by
4 drug-resistant Mtb
5 is increasing, in part due to the long duration (6 months) of combination therapy (4 antibiotics) for drug-sensitve
6 TB (DS-TB), which results in poor compliance. Treatment for DR-TB is even longer, ranging from 6-24 months
7 typically, with 3, 4 or more antibiotics taken in combination. Despite the dire need for new treatments against
8 DR-TB, only one new antibiotic for TB with an entirely novel mechanism of action (MoA) has been approved in
9 the past 40 years, bedaquiline. Therefore, new classes of drugs with new MoAs that can be combined with
10 existing or new TB drugs in the pipeline are desperately needed. The success of bedaquiline, which disrupts
11 energy metabolism in Mtb and has shown promise in reducing treatment times for DR-TB, has accompanied
12 an explosion of drug discovery targeting respiration in Mtb. Fimbrion is developing a thienopyrimidine small
13 molecule series that targets the Mtb QcrB protein
14 electron transport chain in Mtb, has been validated as a drug target by the early clinical success of the QcrB
15 inhibitor, Q203, which is currently in Phase 2 clinical trials, but has potential liabilities. Our goal in this project is
16 to develop a best-in-class QcrB inhibitor that could become part of a shorter drug regimen that effectively treats
17 both DS- and DR-TB. Initially in our Phase I project, we had examples of some very potent compounds, but
18 metabolic stability was poor. Our Phase I goals, therefore, were to optimize stability, while maintaining or
19 improving potency, so that we could test lead compounds in an animal model of Mtb infection. We achieved
20 this goal, identifying a lead THP series of stable QcrB inhibitors with low nM potency, favorable PK properties,
21 including oral bioavailability, and demonstrated in vivo efficacy in a mouse model of acute TB infection. In our
22 Phase II project, we will optimize our lead series with the goal of identifying and de-risking a clinical candidate
23 molecule that is effective in treating TB. Specifically, we will 1) further optimize our lead series to improve drug-
24 like properties and pharmacokinetics, while maintaining or improving our current in vitro potency and in vivo
25 efficacy; 2) investigate: i) the efficacy of lead compounds against diverse Mtb stains and under clinically
26 relevant conditions, ii) the risk of resistance, iii) potential in vitro synergy with other anti-Mtb drugs, and iv) in
27 vitro toxicity and potential adverse drug-drug interactions; and 3) test advanced lead compounds for efficacy in
28 clinically relevant mouse models of TB disease and assess in vivo PK and toxicity in larger mammals to select
29 and de-risk a clinical candidate. Successful completion of this project will lead to the identification of a clinical
30 candidate drug that will proceed to pre-IND studies and attract interest from potential co-development partners.
strains (DR-TB) that are resistant to one or more frontline standard of care (SoC) antibiotics
for the treatment of TB. QcrB, a component of the respiratory

Public health relevance
Project Narrative: Tuberculosis (TB), caused by the bacterium Mycobacterium tuberculosis (Mtb), is a leading cause of human mortality in the world for a single infectious agent and drug-resistance to standard of care frontline and even second-line antibiotics is increasing, highlighting the need for new therapies. In this application, we propose to further develop a lead series of small molecule compounds for the treatment of TB, resulting in the selection of a clinical candidate to progress towards clinical trials. The proposed studies have the potential to result in the development of a new family of anti-mycobacterials to be used to treat both drug-sensitive and drug-resistant TB.